Pre-doctoral Training Program in Molecular Therapeutics

The global objective of the NIH-funded Molecular Therapeutics Training Program (MTTP) is to provide highly
qualified predoctoral students with the knowledge base and research skills to begin independent investigative
and teaching careers in the pharmacological sciences. Rapid advances in biotechnology coupled to the ever-
expanding development of new and repurposed therapeutics has created a growing need for highly qualified
scientists with core training in the principles and practice of pharmacology. The MTTP has had sustained
excellent outcomes and an excess of excellent training grant eligible predoctoral students. Therefore, support is
requested for an expansion of the program from four to six predoctoral positions for all years. The goal of the
program is to develop professional pharmacologists with the maturity to address new research questions through
creativity and collaboration and to communicate their findings to a wide audience documented by publications in
premier scientific journals and effective communication with the lay public. We expect our graduates to be fully
capable of contributing to the design and evaluation of therapeutic strategies in a range of careers. The MTTP
provides a uniform conceptual framework and research environment through which students obtain the PhD
degree in Pharmacology at Case Western Reserve University (CWRU). Designed with a three-tiered
progression, the MTTP first establishes a didactic foundation in cell and molecular biology coupled with research
rotations to facilitate mentor selection. Secondly, a foundation in molecular and physiological pharmacology is
achieved via an intensive two-part core course which emphasizes both quantitative analysis and disease-
focused study of drugs. Thirdly, students specialize via advanced courses and thesis research. In addition, rigor
and reproducibility is a longitudinal component of the curriculum, which emphasizes unbiased experimental
approaches that take into account group size, blinded experiments, and sex as a biological variable. These steps
ensure that the importance of rigor and reproducibility is at the forefront from year 1 through preparation and
defense of the thesis. The thirty-eight MTTP faculty preceptors represent six major research centers in
Cleveland: CWRU, University Hospitals, the CWRU Comprehensive Cancer Center, the Cleveland Clinic, the
Cleveland VA Medical Center, and MetroHealth Medical Center. This rich diversity of research and training
settings is accomplished while maintaining a united focus on pharmacology. The interdisciplinary design fosters
productive interactions among students and faculty in basic and clinical departments around the common theme
of therapeutics. Collectively the MTTP trainers are a highly interactive group of experienced, well-funded
investigators, and there are many examples of collaborative scientific interactions among the program faculty.
The environment at CWRU is excellent for research and training PhD students. Finally, The CWRU SOM is
committed to graduate education and covers all first-year costs of all PhD students entering the MTTP.

Public health relevance
Project Narrative A common foundation in both cell and molecular biology and the physiological and molecular bases of pharmacology for all students is unique to the Molecular Therapeutics Training Program (MTTP) under a rich interdisciplinary collection of trainers from multiple departments and institutions who are carefully selected and unified by their shared research interest in advancing insight for therapeutic development. As students diversify into the advanced courses and thesis research, they remain united by many functions, most importantly the uniform program of study overseen by the MTTP Steering Committee, the Graduate Student Organization (GSO) that fosters educational as well as social interactions on a monthly basis, and the Annual Departmental Retreat that features the scientific accomplishments of the entire program and brings the community of faculty, students and research staff together to enjoy the science as well as recreational activities. These periodic functions are reinforced on a weekly basis by the universally attended Seminar Series in the Pharmacological Sciences and the Departmental Journal Club.